Beyond Diversity: Addressing Equity and Enrollment in a Clinical Trial Network Model

Project Summary/Abstract: In the 40 years since the publication the Belmont Report in 1979 Black, Indigenous, and other people of color (BIPOC) have gone from bearing an undue burden of involuntary participation in clinical research to being excluded from receiving its benefits. Clinical trial populations in the United States are not racially or ethically representative of the US population and these disparities have existed and been studied for decades. Prevailing research primarily attributes such disparities to patient distrust, health literacy, and logistical barriers, all of which overemphasize the role of the individual and do not recognize the role of institutional barriers and structural racism. An opportunity exists to reframe the medical imperative of racial and ethnic parity in clinical trials from one that legitimizes pseudoscientific notions of biological race to one of justice informed by contemporary racial scholarship. This project will present a case study of the Cardiothoracic Surgical Trial Network, a well-established and successful clinical trials network created by the NHLBI to advance the surgical treatment of cardiovascular disease. Despite naming the enrollment of diverse populations as key element of its mission, the CTSN has not reached its stated goal and three of the five most recent studies in have enrolled patient populations that were more than 90% white and non-Hispanic. The primary aim of this study is to assess whether the network model compounds systemic barriers to the recruitment of BIPOC and identify possible interventions using the interdisciplinary framework of Critical Race Theory. Critical Race Theory emphasizes the social construction of race, the structural nature of racism, the positionality of the researcher, the lived experience of marginalized individuals, and the application of research. A quantitative analysis of CTSN trial demographic data and site demographic data will be performed to establish whether there are racial and ethnic disparities related to geographic and site population constraints (structural/institutional discrimination). Based on the quantitative analysis, 3-4 network sites will be chosen for case studies and qualitative interviews will be conducted with site staff. Interview data will be compiled and reviewed using descriptive statistics (positionality). An intervention plan for the network and a site evaluation tool will be developed based on the results of the project (praxis) and can serve as a model for other NIH networks

Public health relevance
Project Narrative: In the United States, publically funded clinical trials are not racially or ethnically representative of the country's population and therefore fail to meet the basic ethical standard of justice in research as outlined in the 1979 Belmont Report. This project looks at a well-established NHLBI clinical trials network, the Cardiothoracic Surgical Trials Network, to assess how the structure of the consortium can be improved to better serve Black, Indigenous and other patients of color and to identify measures to increase their participation in clinical research. If successful, this research could help ensure that studies paid for by the American public benefit and include all Americans.